PARTIAL SUPPORT OF INST OF LABORATORY ANIMAL RESOURCES

1. Be responsible for the development of guidelines and standards for the care and use of laboratory animals used in biomedical research. In addition to developing needed standards/guidelines, the Contractor shall update current publications, previously issued, as needed. 2. Accomplish the above by convening various experts from throughout the field and compiling their expertise into a published standard and/or guideline. 3. Arrange for meetings, arrange and pay for travel for committee members, and print and distribute the publications as requested by persons throughout the biomedical research field.